Bioenergetic and Metabolic Consequences of the Loss of Gonadal Function

The Colorado Specialized Center of Research Excellence on Sex Differences (CO-­SCORE) is thematically
focused on Bioenergetic and Metabolic Consequences of the Loss of Gonadal Function. The overarching
scientific objective of the CO-­SCORE is to advance knowledge of the impact of gonadal aging on the
regulation of bioenergetics, abdominal adiposity, and metabolism by conducting mechanistically-­driven
research across the basic-­to-­clinical translational spectrum. The scientific premise is that gonadal failure
mediates biological changes that increase risk for chronic disease. The most well-­studied example of this is the
accelerated decline in bone mineral density at menopause and the associated osteoporosis risk. However, the
extent to which gonadal failure increases risk for chronic diseases other than osteoporosis is poorly
understood. This is a particularly important knowledge gap in women’s health, because gonadal failure is
inevitable in women in mid-­life, but rare in men until much later in life. The overarching educational objective
is to engage new investigators in research aligned with the thematic focus of the CO-­SCORE. The CO-­SCORE
will promote mentored career development and provide training on how to conduct research that appropriately
addresses sex as a biological variable (SABV). These central objectives will be accomplished through the
following Aims: 1) The three CO-­SCORE Research Projects (basic, preclinical, and clinical) will advance
cutting-­edge, paradigm-­challenging translational research on novel mechanisms postulated to contribute to the
increased abdominal adiposity and associated metabolic dysfunction that occur in the estrogen-­deficient state;;
2) The Career Enhancement Core (CEC) will provide a rich training environment to attract and support
outstanding junior investigators with research interests related to the thematic focus of the CO-­SCORE.
SCORE Scholars and Pilot Awardees will be selected through a competitive process and participate in a
comprehensive career development program;; 3) The Leadership Administrative Core (LAC) will provide
infrastructural support for the Research Projects, CO-­SCORE Pilot Projects, and the CEC, including
biostatistics, data management, financial oversight, and administrative support. An evaluation specialist will
use innovative strategies for assessing whether the research, trainees, mentors, and the CO-­SCORE as a
whole are achieving a high level of impact and reach;; and 4) The CO-­SCORE will partner with other Centers
and Programs at CU-­AMC to elevate the visibility and multi-­disciplinary reach of women’s health research and
the importance of investigating SABV. Activities will target both scientific and lay communities at local, regional,
and national levels. Achieving these Aims will position the CO-­SCORE as a national leader in our targeted
areas of women’s health research, and the CEC as a model program for training junior investigators to
appropriately integrate SABV into their research, thereby addressing the ultimate goal of the SCORE program
of improving the health of women.

Public health relevance
The decline in sex hormones (estrogen and testosterone) with aging can increase risk for certain diseases;; osteoporosis is a well- known example. This is particularly important for women’s health because the loss of estrogen occurs during mid- life, whereas the loss of testosterone in men occurs much later in life. The Colorado Specialized Center of Research Excellence on Sex Differences (CO- SCORE) will advance novel ideas for how the loss of estrogen increases fat gain in the abdominal region, which increases risk for heart disease and diabetes, and strategies that may be effective in preventing this.